Tissue Culture and Biobanking Shared Resource

TISSUE CULTURE & BIOBANKING SHARED RESOURCE: PROJECT SUMMARY
The Tissue Culture & Biobanking Shared Resource (TCBSR) is an integral part of Georgetown Lombardi
Comprehensive Cancer Center (LCCC) research activities and has been funded by the Cancer Center Support
Grant (CCSG) since 1993. Bassem R. Haddad, MD, has led the TCBSR as Director since 2002. The TCBSR
provides services to support LCCC Members with all tissue culture-related aspects of their work. It also offers
unique and necessary services that enable biobanking of blood and other biofluid specimens obtained from
subjects enrolled in various LCCC studies. The tissue culture services available are as follows: (1) cell culture
and cell banking; (2) conditional reprogramming of cells to establish primary epithelial cell cultures from normal
and cancer tissues; (3) Epstein-Barr virus (EBV) B-cell transformation service to facilitate cancer genetics
studies; (4) maintaining the LCCC repository of established cell lines; (5) performing quality control tests for cell
lines, including cell line authentication and mycoplasma testing services; (6) providing a safe and secure
cryostorage facility for investigators to keep frozen stocks of their cancer cell lines and other reagents; (7) testing
and supplying tissue culture reagents of the highest quality that have been tested for suitability in the relevant
systems, as inexpensively as possible; (8) equipping, monitoring and stocking three separate shared tissue
culture laboratories for use by LCCC investigators; and (9) training in the basic principles of tissue culture with
hands-on experience. The TCBSR is also responsible for biobanking blood and other biofluid specimens
obtained from subjects enrolled in various LCCC studies by the Survey, Recruitment, & Biospecimen Collection
Shared Resource (SRBSR) and individual LCCC Members. The biobanking services include the processing of
specimens (e.g., preparing aliquots of serum, plasma, buffy coat and peripheral blood mononuclear cells
[PBMCs]), banking the specimens, and disbursing as needed. The TCBSR continues to be heavily used by a
large number of LCCC Members conducting basic science research, translational research, as well as for some
clinical trials (biobanking). In FY2022, the TCBSR provided services to 38 LCCC Members from all three
Research Programs: 18 from the Cancer Cell Biology Program, 14 from Cancer Host Interactions Program, and
6 from Cancer Prevention and Control Program. Collaboration between TCBSR and seven other LCCC Shared
Resources is an active process, particularly in biobanking where TCBSR works synergistically with the SRBSR
to enable the biobanking of all blood and other biofluid specimens obtained from subjects enrolled by SRBSR in
various LCCC studies. The capabilities of the TCBSR also provided key tissue culture and biobanking support
that enabled the success of 68 extramurally funded research project grants, 8 clinical trials, and 60 peer-reviewed
publications, including 18 published in high-impact journals (e.g. Nucleic Acid Res, Nat Commun, Cancer Res,
J Immunother Cancer, Cancer Immunol Res, and Oncogene) during the current project period.